Circular Dichroism Spectrophotometer

Project Summary
This application requests funding to obtain a circular dichroism (CD) spectrophotometer,
specifically a Jasco J-1500 model with a detection wavelength of 160-1,600nm. The requested
instrument includes a Peltier temperature controller, multi-sample and low-volume sample
capability, fluorescence detection, automatic titration capability and magnetic circular dichroism
capability. The acquisition of this state-of-the-art piece of equipment will enhance opportunities at
SJSU and our partner institutions, enabling users to further their research and education goals,
and further increasing and diversifying the U.S. biomedical research enterprise. This instrument,
with 7 major users and 6 other users, will greatly expand our research abilities in the fields of
biochemistry, inorganic chemistry, organic chemistry, materials science, nanotechnology and
bioengineering, as well as provide our students hands-on access to advanced biochemical
analysis techniques through lab courses. In addition to supporting research and education within
San José State University (SJSU), this instrument will also support external users from Santa
Clara University. The research labs supported by this grant have received various external
funding from federal agencies such as NIH and NSF and have published extensively in peer-
reviewed journals in their respective fields. The laboratory course supported by this application
serves senior biochemistry students at SJSU.
This instrument will greatly expand the research capacity of our users by providing higher
efficiency and sensitivity in current areas of research as well as introducing new research abilities
that were not possible before. The institution currently houses a CD instrument that is >20 years
old and has been discontinued. The new CD instrument will have a vast improvement in sensitivity
and efficiency, enabling researchers to characterize the structure, stability, and ligand interactions
of proteins and peptides with much higher throughput and obtain more detailed information. More
importantly, the near IR wavelength extension to 1,600 nm and the addition of the magnetic CD
add-on will allow for the characterization of non-biomolecules, such as chiral small molecule
ligands, stable radicals, and metal centers in organometallic complexes, experiments that were
not previously possible at our institution.
In addition, this instrument will support a capstone lab course where senior biochemistry
students will now have the chance to structurally characterize their proteins in a Course-based
Undergraduate Research Experience (CURE) project. This hands-on experience will help prepare
students for future careers in academia and industry.

Public health relevance
Project Narrative We request the purchase of a circular dichroism spectrophotometer. This instrument is crucial in characterizing the structure and stability of molecules involved in human diseases, drug development and delivery, antibiotic resistance and biomaterials. This instrument will greatly increase the breadth, depth and efficiency of research at SJSU and surrounding institutions; as well as give students hands-on experience in a classroom setting to help enhance their career-related skills.